A computational framework for quality assessment and curation of models at scale

Project Summary
Model development is a common step of a research pipeline in many domains, including biology. However, most
often there is no systematic approach to annotate models during their development stage, which can complicate
their evaluation and reuse in the following stages of the research pipeline. Computational and systems biologists
create models of various biological systems, a procedure that, even when partially automated, often takes
months, or even years, to achieve a trusted model. The verification step, assessing whether model’s components
are correct by finding support for all its elements and interactions, and the validation step, evaluation of model
behavior against experimental observations and data, usually occur iteratively with model expansion before the
model can be used to make predictions or explanations. A standardized procedure for model verification and
validation including well-defined requirements for model annotations at these stages is still lacking. Once
published, models are usually added to one of the existing model repositories and databases. Most of the steps
described above are done manually. On the other hand, recent advances in natural language processing (NLP)
and large language models (LLMs) have enabled processing thousands of papers and the rapid extraction of
entity, event, and causal relationship information. Several tools have been developed to collect this information
and ground it to standard database identifiers. These text mining resources can be utilized when automatically
verifying and validating the existing or newly built models. Our goal is to standardize and fully automate the
iterative process of assembly, documentation, verification, and validation of models of cell signaling. This will
maximize the model accuracy and reuse potential and their long-term value, while minimizing the risk of models
becoming obsolete. The objective of this research project is to develop an architecture that will allow researchers
to automatically assess the quality, annotate and expand their models, utilizing available literature and model
databases. These objectives will be accomplished by carrying out three Specific Aims: 1. development of a
framework architecture to automatically verify, validate, document, and increase the completeness of models of
cellular signaling, 2. development and implementation of methods to automatically identify and resolve
contradictions in available information, or suggest conflict resolution, and 3. development of translators and
interfaces to ensure compatibility of our methods with model formats used by existing knowledge bases and
databases, and to streamline communication between our architecture and these online sources. At the
conclusion of this project, we will have designed, implemented, tested, and made publicly available this
framework that will enable model curation at scale with automated verification, validation, documentation, and
improvement of both new models during their development stage, as well as existing models. Outcomes of this
work will contribute to the substantial increase in the quality and reuse of models and aid computational and
systems biology researchers in assembling or selecting comprehensively annotated and trusted models.

Public health relevance
Project Narrative Although modeling is an important component of a research pipeline in biology, there is no systematic or standardized approach for quality assessment and annotation of models, thus reducing their trustworthiness and reuse potential. Our goal is to standardize and fully automate the iterative process of assembly, documentation, and assessment of models of cell signaling, and as such, maximize the model reuse potential and their long- term value, while minimizing the risk for models to become obsolete. The objective of this proposal is to develop a computational framework that allows researchers to automatically verify, validate, annotate, modify, and update their models using open access information in published literature and databases.